Investigating Neuromelanin-Mediated Locus Coeruleus Neurodegeneration in a Novel Mouse Model of Parkinson's Disease

Investigating neuromelanin-mediated locus coeruleus neurodegeneration in a novel mouse model of Parkinson’s disease
Alexa Iannitelli
Summary
Parkinson’s disease (PD) is the second most common neurodegenerative disorder worldwide, and is characterized by motor
and non-motor symptoms. The leading pharmacotherapy, levodopa, is only effective for treating the motor symptoms caused
by dopamine (DA) neuron degeneration, while non-motor symptoms associated with noradrenergic dysfunction have grave
consequences for the quality of life experienced by PD patients and are not alleviated by any currently available therapies.
Thus, new research on PD neuropathology and treatment must consider the locus coeruleus (LC), the major central
noradrenergic nucleus. The LC develops alpha-synuclein pathology prior to DA neurons in PD and is almost completely
degenerated in later stage disease, but the molecular mechanisms responsible for its vulnerability are unknown. Along with
substantia nigra DA neurons, the LC is the only structure in the brain that produces appreciable amounts of neuromelanin
(NM), a dark brown cytoplasmic pigment. It has been proposed that these NM granules initially play a protective role by
sequestering toxic catecholamine metabolites and heavy metals, but become harmful during aging and particularly in PD as
they overwhelm cellular machinery and get released during neurodegeneration. Because rodents do not naturally produce
NM, the study of this pigment has been mostly limited to human postmortem studies, and it has not been possible to
experimentally address the role of NM in PD-associated LC pathology. However, I have adapted a viral-mediated approach
for expression of human tyrosinase, the enzyme responsible for the development of melanin in skin cells, to promote NM
production in rodent LC neurons. I found that pigment expression in the LC recapitulates key features of endogenous NM
found in primates, including eumelanin and pheomelanin, lipid droplets, and a double-membrane encasement. By 10-weeks
post-injection, mice display severe LC neurodegeneration and a robust neuroinflammatory response, resulting in astrocytic
glial scarring. Behavioral consequences include hyperarousal, increased anxiety-like behavior, and cognitive impairment.
These phenotypes reflect non-motor symptoms of PD, validating the utility of this model for studying the consequences of
NM accumulation in the LC as it relates to neurodegenerative disease. During the F99 phase, I propose to expand these
findings by employing the ribo-tagging technique Translating Ribosome Affinity Purification (TRAP) to investigate how
changes in gene transcription relate to, and potentially underlie, NM-induced LC dysfunction and degeneration. In the K00
phase, I will apply the information gleaned from these studies to investigate potential mechanistic and pharmacological
interventions in the hopes of mitigating toxic NM accumulation and subsequent neurodegeneration, in both the LC and SN.
These studies will provide a comprehensive understanding of how NM contributes to the early vulnerability of
catecholamine neurons in PD, and will help identify potential molecular targets for the prevention and treatment of this
debilitating neurodegenerative disease.

Public health relevance
PROJECT NARRATIVE Parkinson’s disease (PD) is the second most common neurodegenerative disorder, affecting nearly 1 million individuals and their families in the United States, with patients suffering from both progressive motor symptoms, such as bradykinesia and tremor, along with debilitating non-motor symptoms, including anxiety and depression, sleep disturbances, and cognitive decline. Incidence rates of PD will continue to rise as the population ages, presenting a significant public health problem as there is currently a lack of disease-modifying therapies and effective therapeutic treatments for improving the troublesome non-motor symptoms. This project will test the hypothesis that dysfunction of the locus coeruleus-norepinephrine system is implicated in the non-motor symptoms of PD, and that modulation of pathways identified to be dysregulated can provide insight into the development of more effective therapeutic treatments for PD patients.